Division of Chemical Toxicology Symposia at the 268th National ACS meeting

The goal of this application is to obtain support for the American Chemical Society Division of Chemical
Toxicology (TOXI) at the 268th National Meeting, which will be held August 18-22, 2024, in Denver, CO. The
mission of the Division of Chemical Toxicology is to improve human health and public welfare by promoting the
understanding of chemical mechanisms that govern disease processes and the toxicity of drugs, environmental
agents, and endogenous chemicals. Our goals include providing a diverse forum for communicating research in
the field of chemical toxicology, encouraging research in chemical mechanisms of toxicity, and facilitating
connections between academia, industry, and policy in scientific areas of mutual interest. We are also committed
to developing the leadership and professional development skills of scientists from all levels and backgrounds.
Thus, the requested funds will be used to support travel awards and expenses for graduate students,
postdoctoral scholars, and junior faculty. The overall TOXI program is organized around the theme of
“Toxicological Predictions, Markers, and Outcomes Affecting Human Health” and complements the National
Meeting theme of Elevating Chemistry. The program includes five thematic symposia, which will feature invited
oral presentations by a diverse group of established and emerging investigators with a range of perspectives on
each topic. The five thematic symposia are: (1) “Application of Augmented Artificial Intelligence in Toxicology
Metabolism Prediction”, co-promoted by the Division of Chemical Information (CINF) and Medicinal Chemistry
(MEDI), will explore the role of augmented AI in predicting toxic metabolites; (2) “The Role of Investigative
Toxicology in Drug Discovery & Development”, co-promoted with MEDI, will provide insight into the role of
investigative toxicology in a drug discovery setting; (3) “Revealing Toxicological Mechanisms of Small Molecules
using Chemical Biology”, co-promoted with the Divisions of Biology (BIOL) and Organic Chemistry (ORGN),
focusing on the innovative and creative use of chemical biology and functional omics strategies that reveal the
mechanisms by which small molecules affect toxicity or alter biological activity; (4) “Advances in Forensic
Toxicology”, co-promoted by the Society for Forensic Toxicology, focusing on the application of toxicological
methods, studies, and knowledge to situations with medico-legal consequences; (5) “Women in Toxicology”, co-
promoted with Chemical Research in Toxicology, will highlight the work of women in toxicology and explore how
they are making strides to improve sustainable living throughout the world. The scientific program is clearly
aligned with the mission of NIEHS.

Public health relevance
The ACS Division of Chemical Toxicology (TOXI) is dedicated to advancing our understanding of chemical processes related to disease development and the harmful impacts of environmental agents, drugs, and natural compounds, with the overarching goal of improving public welfare and human well-being. Specifically, this initiative aims to support TOXI's scientific program at the ACS National Meeting, focusing on sessions that highlight the mechanisms and predictions of how environmental agents or their byproducts induce toxicity. Through this conference, recent discoveries are shared, fostering collaboration among environmental health scientists and chemists from diverse specialized fields, aligning with the health mission of the National Institute of Environmental Health Sciences (NIEHS) and the National Institutes of Health (NIH).